Development and application of a quantitive model for HIV-1 transcriptional activation driven by TAR RNA conformational dynamics

Project Summary
Many processes essential for HIV-1 viral replication are driven by the association of regulatory RNA elements in
the retroviral genome and host/viral proteins that form biologically active complexes. Despite advances in solving
the 3D structures of RNA-protein complexes and in measuring RNA-protein interactions in vitro and in cells, our
current understanding of RNA-protein interactions is qualitative and not quantitative, descriptive, not predictive.
Attaining a quantitative and predictive understanding is necessary to reveal the forces and conformational states
driving viral processes and to fully define the landscape of opportunities for therapeutic intervention. The
overarching hypothesis of this proposal is that the cellular transcriptional activity of HIV-1 TAR RNA can be
predicted from its sequence based on its conformational propensity to form the binding-competent conformation
and its affinity for the transactivator protein Tat and the human super elongation complex (SEC) Tat:SEC. The
project will (i) develop a suite of technologies to obtain experimental data on RNA ensembles, RNA-protein
interactions, and cellular activity quantitatively in high throughput over a large and common expanse of RNA
sequence and structure space (ii) closely integrate NMR data with computational molecular dynamics (MD)
simulations and empirical RNA structure prediction algorithms (FARFAR) to determine RNA ensembles free and
bound to proteins and to test and guide refinement of the computational models through a community wide effort;
and (iii) test and refine a thermodynamic model predicting cellular function that dissects TAR•Tat:SEC binding
energetics into contributions from intermolecular contacts and conformational propensities. From a common
library of 1000s of TAR RNA variants, Aim 1 will determine conformational propensities and measure binding
affinities to Tat and Tat:SEC across solution conditions and measure transcriptional activation in cells and with
Tat concentration varied. The data will be used to develop a quantitative and predictive model for cellular
transcriptional activation based on in vitro measurements and iteratively refine the model. Aim 2 will integrate
NMR data with MD simulations and FARFAR; determine atomic-resolution ensembles for 20 TAR variants, free
and bound to the Tat RNA binding domain; use the ensembles to define the bound conformational states and
refine conformational propensities; identify strengths and weaknesses of MD and FARFAR; and develop and test
a new method (FARFAR-CS) for determining RNA ensembles and use it to refine propensities for 100s of TAR
variants. Aim 3 will extend the model to include alternative secondary structure propensities, use NMR
experiments to measure these propensities for 100s of TAR variants, and extend the model to include binding
of 20 small molecules and competition with 7SK RNA for 1000s of RNA variants. When completed, this project
will make it possible to quantitatively predict cellular transcriptional activity from TAR sequences, will reveal the
profound contribution of conformational propensities to RNA-protein binding, and will provide a roadmap for future
efforts that link biochemical and biophysical properties to molecular behavior and function in cells.

Public health relevance
Project Narrative The proposed research is relevant to public health because it develops a deep and predictive molecular understanding of a process crucial for HIV-1 replication and may give rise to improvements in our ability to rationally interfere with this process for therapeutic intervention. Upon conclusion of the proposed studies, we will better understand the mechanisms that underlie RNA-protein interactions and the role of RNA structural dynamics in HIV-1 replication.